Maintenance of the Animal Feed Regulatory Program Standards with Coordinated Preventive Control Regulatory Activities and Capacity Building in South Carolina

Summary-Abstract
The South Carolina Department of Agriculture (SCDA) seeks funding support for costs associated
with maintaining a comprehensive and integrated animal feed safety program, allowing for six
final months of development followed by three years of maintenance with the Animal Feed
Regulatory Program Standards (AFRPS). Funding is also being sought to expand independent PC
and cGMP inspections under South Carolina state authority.
SCDA Consumer Protection Division (CPD) has been involved in the process of AFRPS compliance
since 2014. Initially, the primary obstacle to achieving conformance with the Standards was
insufficient staffing. To overcome this barrier, SCDA applied for and began the AFRPS
Cooperative Agreement Program (CAP) with FDA in 2017. Currently in the fifth year of this
agreement, three full time personnel are employed with AFRPS funding, one AFRPS Coordinator,
one Feed Safety Inspector, and one Feed Safety Compliance Officer are exclusively dedicated to
the successful development and maintenance of the SCDA Feed Program. The Feed Program
Manager and one additional Feed Safety Inspector have also been employed partially by AFRPS
funding to aid in the inspectional efforts of the Standards. These five personnel are also
anticipated to aid in the PC Funding Option requirements.
2

Public health relevance
Project Narrative The South Carolina Department of Agriculture (SCDA) has achieved full implementation of all eleven of the Animal Feed Regulatory Program Standards (AFRPS) as determined by its audit in November 2021. Through this cooperative agreement, SCDA will continue to use systematic methods to maintain these achievements along with identifying and overcoming obstacles to full conformance and incorporating more Preventative Control Inspections. The South Carolina Feed Safety Program will continue to enhance its efforts towards the regulation of animal feed safety. 1